Understanding HIV/STD Risk and Enhancing PrEP Implementation Messaging in a Diverse Community-Based Sample of Gay, Bisexual, and Other Men Who Have Sex with Men in a Transformational Era

Abstract
The prevention of HIV in the United States is in a transformational era. In just a decade since the first finding of
efficacy for daily oral PrEP, there is a proliferation of new PrEP agents, including long-acting injectable PrEP,
and regimens, including “event-driven” (also called 2-1-1) PrEP. There has also been new knowledge about the
impact of antiretrovirals (ARVs) for treatment of HIV, and an emergent understanding that people living with HIV
who take ARVs and maintain a suppressed viral load are incapable of transmitting HIV to their sexual partners.
In this context, the idea of “protected” sex – which historically meant sex protected by condoms – has become
much more complex. To understand men’s preferences for prevention products and strategies and what choices
are being made by men with varying risk profiles, we will enroll a prospective cohort of 1275 of men who have
sex with men (MSM) in Atlanta, Detroit and San Diego and follow the cohort for two years. Each participant will
have 8 quarterly quantitative assessments, including discreet choice experiments; a subset of MSM will be
engaged in a qualitative assessments (focus group discussions and individual in-depth interviews) to help with
message development and refinement. HIV and STI testing will be provided in alternating 6-month windows.
Rapid reporting of results will produce actionable reports following each assessment wave. This project will
serve as a dynamic source of data about the evolving patterns of use and preference for PrEP among MSM.

Public health relevance
Narrative The prevention of HIV in the United States is in a transformational era. To understand men’s preferences for prevention products and strategies and what choices are being made by men with varying risk profiles, we will enroll a prospective cohort of 1275 of men who have sex with men (MSM) in Atlanta, Detroit and San Diego and follow the cohort for two years, with HIV and STI testing, quarterly quantitative assessments and qualitative assessments.